Probing transcriptional activation at the molecular level

Project summary
Our work has focused on answering two fundamental and long-standing questions in transcription initiation:
what are the underlying molecular recognition principles governing transcriptional activator (TA)-coactivator
complexes and, relatedly, are the complexes druggable. The importance of these questions is apparent
considering the central role TA-coactivator complexes play in steering the assembly of the transcription
machinery at gene promotors. Early in transcription, coactivators are recruited to genomic loci by DNA-bound
TAs and it is the transient and structurally dynamic TA-coactivator PPI network that promotes essential
epigenetic alterations and primes RNA polymerase for transcription initiation. Conversely, dysregulation of
TA-coactivator PPIs is implicated in numerous pathologies and for that reason TA-coactivator PPIs are high-
value targets for probe molecules and therapeutics. Here we will harness the molecular recognition principles
and synthetic modulator discovery strategies developed in the previous funding period to re-wire
transcriptional circuits that are dysregulated in cancer and intellectual disability. In doing so we will provide a
set of synthetic inhibitors and enhancers of TA-coactivator complexes available to the broader community and
deﬁne druggable nodes for therapeutic development.

Public health relevance
Project narrative Transcription is dysregulated in every human disease as either a cause or an eﬀect and as such represents a potentially powerful intervention point for therapeutics; a signiﬁcant impediment to progress are the many questions regarding the complex network of protein-protein interactions that regulates this process. In this research plan we implement a combination of chemical biology tools and approaches to deﬁne key binding interactions and conformational changes that produce function in vitro and in cells. In doing so, we will discover new opportunities for drug discovery, with a particular focus on transcriptional pathways integral to intellectual disability and cancer.